Interdisciplinary Training for Autism Researchers

Abstract
Autism spectrum disorder (ASD) affects 1 in 59 children with (1) multiple
developmental/behavioral impairments (social communication, motor development,
movement, cognition, emotional responses, sensory responses, behavior, cognition,
psychiatric symptoms); (2) health difficulties; and (3) associated biological abnormalities
(genetic, immunology, brain function/ structure, neurochemistry, environmental factors).1
Persons with ASD live in families and communities, receive many interventions and
services, and yet only 8-12% of adults are able to manage typical adult life demands
successfully. The public health/education needs are enormous. This program will
improve outcomes of people with ASD by training >25 talented, diverse, postdoctoral
fellows/residents in two-year cohorts to conduct ASD science as collaborating members
of interdisciplinary teams, to add knowledge about its causes and mechanisms, and to
develop, test, and translate new treatments into communities.

Public health relevance
Project Narrative Autism spectrum disorders affect 1 out of 59 persons with life-long effects on psychiatric well- being, social relations, educational and vocational success, and community participation and contribution.1 Life-long supports are often needed, the effects of which challenge public health and social systems, as well as personal, family, and community wellbeing. According to Dr. Thomas Insel, director of NIMH, "The …nation, recognizes the urgent needs of the autism community, and presses on toward the goal of transformative scientific discoveries and enhanced services and supports that will make a difference in the lives of individuals and families living with ASD." This interdisciplinary autism research training program, now in its 14th year, addresses the public health challenges of ASD by preparing scientists to make transformative discoveries in the bio-psycho-social aspects of autism and related disorders that will lead directly to new and improved medical and behavioral treatments, in order to reduce psychiatric and developmental impairment and the public health challenges that these entail, improve community services and participation for persons with ASD and their families, and most importantly, enhance quality of life and functional outcomes for persons with ASD and related disorders.